New Frontiers in Cardiovascular Research and Therapy

PROJECT SUMMARY This proposal requests NHLBI support for the Scientific Sessions meeting presented by the Council on Basic Cardiovascular Sciences (BCVS) of the American Heart Association (AHA). This meeting has become the “go to” meeting for basic and translational cardiovascular sciences by providing opportunities for established and emerging investigators to present their work and receive constructive feedback. The meeting in 2021 represents the sixteenth consecutive annual conference. Funding for BCVS Scientific Sessions from National Heart, Lung and Blood Institute (NHLBI) has been secured for 14 of the last 15 years. The BCVS summer conference is entitled New Frontiers in Cardiovascular and Research Therapy and is scheduled for July 26- 29, 2021. In 2020, we offered a virtual conference with concurrent sessions and the meeting was attended by over 1000 participants. In 2021, the meeting will begin on a Monday and run through Thursday. In 2021, should it be possible, we will hold the meeting in Chicago. Should we be unable to hold the meeting in person, we will shift to the highly successful virtual format used for the 2020 meeting. The conference will highlight basic cardiovascular research with implications for cardiovascular health and disease. There are 17 scheduled sessions that include a mix of established and emerging investigators. The keynote address will be given by Dr. Douglass Mann. There is a specific session for those in the early career phase. We will host special sessions for networking including interactions with journal editors and staff. We will also include the Women in Science networking event. At every step, we focus on diversity and inclusivity to promote the very best cardiovascular science. This R13 proposal is designed to provide support to young investigators to enable their participation in the meeting as presenters either in oral or poster format. The primary organizers are Drs. Pilar Alcaide and Sumanth Prabhu. The Program Committee (12 members) includes the past program co- chairs and a diverse leadership (both US and international) drawn from the many disciplines encompassed by BCVS. The AHA will continue to provide excellent administrative support with dedicated staff for the logistics of the conference. We fully anticipate that this team will coordinate an outstanding 2021 BCVS conference.

Public health relevance
PROJECT NARRATIVE This award will support the summer meeting for the Basic Cardiovascular Sciences Council of the American Heart Association. The purpose of this meeting is to allow scientists to exchange information on the basic mechanisms of heart disease to help stimulate collaborations and new investigation. We also promote the careers of emerging scientists and trainees.